Imaging and Histology Core

Abstract
An essential component of Phase III CoBRE funding for the Center for Cancer Biology Research (CCBR) is
support of the Histology & Imaging Core (Core B). The Imaging Core, established in 2007, and the Molecular
Pathology Core, established in 2011, were both extensively utilized not only by CCBR investigators but also
those at Sanford Research at large as well as investigators from regional institutions. Their merging to establish
the Histology & Imaging Core in 2018, united these highly utilized cores to provide more efficient support from
staff offering extensive expertise in these areas. In addition to providing state-of-the-art equipment, the Histology
& Imaging Core staff provide a wide array of services (standard and custom) that afford investigators high quality
data without the investment of their time for troubleshooting or obtaining expertise in the technique. Continued
CoBRE support for this Scientific Core as it transitions to a schedule of fee-for-services will provide the necessary
time to obtain self-sustainability. As this Core expands its services, it will continue developing a larger collection
of clients. In this way, self-sufficiency will be attained. Already, the reputation of the Core's quality work and quick
turnaround has expanded regionally resulting in its increased usage. CoBRE funding through Phase III will
ensure successful self-sustainability will be obtained.